Prophylactic Intra-Operative VT Ablation in High-Risk LVAD Candidates

ABSTRACT
The use of left ventricular assist device (LVAD) for patients with advanced heart failure has continued to
increase over the years. The significant improvement in survival with the current generation of LVADs is in large
part due to the advances in device durability, and mechanics. However, several important factors continue to
limit the benefit of LVAD support and ventricular tachyarrhythmias (VTA) following LVAD implantation has been
suggested to be associated with subsequent repeat hospitalization and increased mortality. Our retrospective
data from the University of Rochester have shown that patients who developed VTA following LVAD implant
experienced a 7-fold increase in subsequent mortality risk. Importantly, we have also shown that the most
powerful predictor of VTA post LVAD implant is a history of VTA at any time prior to the LVAD. Several ablation
trials have demonstrated reduction of recurrent VTA and, in selected at-risk patient groups with ischemic heart
disease, mortality. These findings suggest an effective early intervention with VTA ablation peri-LVAD
implantation in high-risk patients, specifically those with a history of VTA, may reduce VTA recurrence and
improve clinical outcomes. Utilization of this strategy has varied amongst centers as there are no prospective
data on the efficacy and safety of this management. Accordingly, we propose a prospective, randomized,
multicenter clinical trial that will evaluate prophylactic intra-operative VTA ablation in high-risk LVAD recipients
on clinical outcomes. The study cohort will consist of 100 LVAD candidate patients with a prior history of VTA
and ischemic cardiomyopathy randomized to either prophylactic intra-operative VTA ablation vs. conventional
medical management in a 1:1 fashion. Eight high-volume LVAD implant centers with experience in VTA ablation
will participate.
The primary specific aim is to evaluate the effect of prophylactic intra-operative VTA ablation at the time of
LVAD implantation on post-implant total recurrent VTA events after accounting for the competing risk of death.
Secondary specific aims are: 1) To evaluate the effects of a management strategy that incorporates intra-
operative VT ablation at the time of LVAD implantation on adverse clinical outcomes following LVAD
implantation; 2) To collect prospective data on peri-procedural outcomes associated with the proposed novel
approach of prophylactic intra-operative VT ablation. We will also explore the mechanisms associated with: a)
recurrent VTA post LVAD implant with electrophysiology studies and b) the ramifications of recurrent VTA on
right ventricular hemodynamics post LVAD implant with echocardiographic ramp studies and right heart
catheterization.

Public health relevance
Project Narrative Ventricular tachycardia is a life-threatening heart rhythm disorder that can complicate the course of patients with advanced heart failure and heart assist pumps (left ventricular assist device; LVAD). Ablation can be an effective treatment that modifies that scars in the heart leading to short circuits causing ventricular tachycardia. The goal of this clinical randomized trial is to determine if an intraoperative VT ablation can help reduce ventricular tachyarrhythmias in patients undergoing LVAD implantation.